Augmented Reality Personalized Motion Tracking Assessment and Improvement Technology for Fall Prevention in a Community Setting Using Mobile Phone

More than 1 in 4 people 65 and older fall each year, leading to more than $50 billion in annual spending for treatment,
and on an upward trajectory. Exercise programs are proven to reduce fall risk for older adults, by improving muscle
strength, balance, and gait instabilities. Fall prevention programs are encouraged by the CDC, NIA, and many other
organizations, and are often provided by community-based organizations and other institutions. While fall prevention
programs are an effective intervention, the impact of current programs is mitigated by cost to administer, lack of
scalability, inability to reach underserved populations, lack of encouragement of ongoing usage, and inability to track
adherence and health outcomes in a systematic way. Older adults are typically unaware of proper exercise regimens for
their specific needs. Currently, the project team believes no fall prevention programs -- either at community centers,
other establishments, or at home -- are delivered nationally, affordably delivered, and efficiently administered to broad
populations that achieve adherence with effective outcomes. KINIMA Inc., is a women-owned company incorporated in
2016 and incubated in both University of Pennsylvania’s Wharton Venture Initiative Program and Stanford University’s
StartX and commercially offered. THE KINIMA Seniors latest offering is a ground-breaking, novel technology that uses
computer vision with no on-body sensors, an innovative side-by-side view through augmented reality guidance with
proprietary content, body joint tracking and artificial intelligence, plus multiple forms of feedback to provide a digital
2-way comprehensive fall prevention exercise platform.The proposed Phase I study seeks to determine the KINIMA
Seniors mobile phone motion tracking platform’s feasibility, acceptability, and accuracy to support fall prevention in
community-based settings. To that end, project AIMS are: 1) evaluate KINIMA Seniors acceptability, engagement and
capability for subjects to complete sessions with little or no intervention by human staff; 2) determine specific forms of
content that best promote the desired physical movement among the targeted populations, including: guided exercises,
movements, video genres, assessments, feedback, gamification and rewards; and 3) determine the effectiveness of the
KINIMA technology for automated tracking of participant usage and movement for supporting productive fall prevention
activities with widely accepted fall risk measures. The KINIMA automated assessments will be compared against tracking
by a human, which is the approach taken by most clinicians today to assess fall risk. These AIMS support the NIA’s
mission and research priorities focused on helping senior adults age in place through the use of assistive devices and
technologies. KINIMA Seniors assistive mobile application will support older adults, caregivers, and therapists in
mitigating age-related physical challenges, particularly in fall prevention. Computer vision and augmented reality features
enable real-time user feedback without wearables or other gear —on-screen visual guide-rails, duration counting, and
repetition tracking; KINIMA automated tracking is done instantaneously and will be measured against tracking by a
human to assess concordance. KINIMA Seniors has enormous commercial potential, and this Phase I study is a major
milestone along that path to commercialization and allows project overseers to assess user acceptability of the features
and effectiveness of the automated measures. Phase II will continue with determining the efficacy of the platform in
improving fall risk outcomes through measuring progress over time.

Public health relevance
Fall prevention represents a public health priority, afflicting 1 in 4 senior adults at a cost of over $50 billion annually, and leading to declines in quality of life and inability to age in place for many older adults. Existing fall prevention modalities can be labor intensive, difficult to scale, inaccessible to certain underserved populations, and difficult to track adherence and outcomes, creating an opportunity for a technology-enabled fall prevention platform to improve access, adherence, and ultimately the trifecta of fall prevention: strength, balance, and gait improvement. KINIMA Seniors provides a mobile assistive technology for fall prevention in older adults, leveraging computer vision, augmented reality, robust content, automated data collection, and a novel user interface in a revolutionary cost-effective approach to greatly scale and commercialize this technology-powered platform for fall prevention activities, with the ultimate goal of improved health outcomes, increased aging at home with less injuries, enhanced good health and higher quality of later life.